Function of Zymogen Granule 16B (ZG16B) in Salivary Glands

Project Summary
Oral inflammatory conditions such as Chronic graft versus host disease (cGVHD) and Oral Lichenoid Lesions
(OLL) commonly affect oral exocrine tissues including minor salivary glands (MSG) that require incisional tissue
biopsy for diagnosis. Saliva, a biofluid with complex composition, is secreted by the acinar cells of salivary glands
to help in important oral functions such as lubrication, digestion, and importantly, to elicit anti-inflammatory
responses providing the potential to present specific biomarkers that reflect health and disease status. Being
able to collect saliva through patient-friendly, non-invasive methods is an important advantage of utilizing this
biofluid for oral and systemic disease diagnostics. Recent shotgun proteomic screening work from our laboratory
identified a significant reduction in protein content of zymogen granule 16B (ZG16B), a jacalin-related lectin
protein, at onset of salivary gland cGVHD compared to healthy donors. Lectin proteins have a carbohydrate
domain and adjacent positively charged binding pocket that can facilitate cell-to-cell interactions and
immunomodulation contributing to important oral cavity tissue homeostasis. Therefore, we hypothesize that
ZG16B is required to coordinate the localization and release of acinar cell secretions. Changes in ZG16B levels
in states of altered oral tissue homeostasis can signal salivary gland damage. Aims 1 and 2 focuses on
determining the distinct binding partners of ZG16B in human salivary gland (HSG) cells and conditioned
media as well as its functional consequence. This will be fulfilled by endogenous co-immunoprecipitation,
mass spectrometry, loss-of-function and gain-of-function experiments followed by entire RNA sequencing
analysis. Aim 3 will quantify the changes in concentration of salivary ZG16B using sex-matched samples
from healthy individuals and saliva from patients with various oral inflammatory conditions damaging
salivary gland (oral cGVHD and OLL). This will be fulfilled using ELISA-based salivary ZG16B screening
validated with immunohistochemistry staining using tissue slides. The completion of this project will provide
rigorous training in biochemistry, salivary gland biology and saliva-based diagnostics enhanced in an
interinstitutional research agreement (NIH Graduate Program Partnership) between Indiana University School
of Dentistry (IUSD) and National Institute of Dental and Craniofacial Research (NIDCR). This collaboration
incorporates excellent mentorship in clinical and translational research to prepare the applicant for a career as
a dentist-scientist.

Public health relevance
Project Narrative: Salivary proteome analysis could identify risk factors of the salivary gland tissues in chronic oral inflammatory conditions such as chronic graft-versus-host disease (cGVHD) and lichenoid lesions (including oral lichen planus). Recently, our lab quantified a decrease in the salivary levels of zymogen granule 16B (ZG16B), a jacalin-related lectin protein, in the saliva of cGVHD observed in survivors of allogeneic hematopoietic stem transplants (HSCT). This project aims to further elucidate the functional consequences of ZG16B through the changes in saliva content of ZG16B (healthy vs. oral inflammatory conditions), identify relevant protein-protein binding partners and contributions to cell signaling pathways.